Visual Remediation in Schizophrenia

Abstract
It is increasingly clear that people with schizophrenia have a range of visual perception impairments,
including in low-level vision (e.g., acuity, contrast sensitivity) and mid-level vision (e.g., perceptual
organization, coherent motion detection). These impairments are significantly related to poorer
performance on cognitive (e.g., visual learning and memory) and social cognitive (e.g., facial
emotion decoding) measures, and to worse functional outcomes. To date, there is no accepted
technique for visual remediation for schizophrenia, and almost no work has been done in this area.
However, visual remediation is a well-developed subfield within cognitive rehabilitation for TBI
patients, and initial studies of short-term visual perceptual learning in schizophrenia indicate that
plasticity exists that could support longer-term changes. Therefore, the overall goal of the proposed
project is to test a visual remediation intervention for schizophrenia and determine its effects on
specific visual targets with well-understood neurobiological mechanisms. The goal of the R61 is to
determine the optimal intervention for improving the targets of contrast sensitivity (CS) and
perceptual organization (PO). Extensive evidence exists for impaired CS and PO in schizophrenia.
Moreover, these targets are prototypical examples of gain control and integration, respectively,
which were identified by the NIMH-sponsored CNTRICS initiative as being the two core mechanisms
involved in visual disturbances in the disorder. We will examine two computer-based interventions.
One, ULTIMEYES (UE), targets CS. The other, contour integration training (CIT), targets PO. We
will also examine the effects of combined treatment (UE&CIT). An active computer-based control
treatment will be included. There will be 40 sessions, with assessments after every 10 sessions
(N=20/group). The R61 Specific Aim is to evaluate the effects of UE and CIT on CS and PO targets,
respectively, to determine if treatment effects meet a pre-specified effect-size criterion. Results of
the R61 will be used to identify the treatment (UE, CIT, or UE&CIT) and duration (i.e., dose) that
most effectively and efficiently improves the target(s). The goal of the R33 is to conduct an initial
randomized controlled trial (RCT) of the optimal treatment identified in the R61. The R33 Specific
Aims are to: 1) replicate and extend R61 results supporting visual target engagement in an
adequately powered RCT (N=50/group); and 2) determine if visual target engagement is associated
with improvements in cognition, social cognition, and functional capacity. If the R33 hypotheses are
confirmed, results will inform the design of a later RCT to further explore mediators and moderators
of treatment effects, and to move towards a precision medicine approach, wherein we determine
which individuals are most likely to benefit from this intervention.

Public health relevance
It has become increasingly clear that people with schizophrenia have visual impairments that affect cognitive and social function in schizophrenia. The primary goal of the first phase of this project is to study the effects of two novel computer-based visual remediation interventions on visual perceptual deficits in schizophrenia. The primary goals of the second phase are to test the effectiveness of the optimal intervention on visual perception in a larger sample, and to test the link between improvements in visual perception and changes in specific higher level functions (cognition, social function and outcome) in preparation for a fully-powered clinical trial.